Culturally Augmented Learning In Biomedical Informatics Research (CALIBIR) Program

PROJECT SUMMARY/ABSTRACT
The Culturally Augmented Learning In Biomedical Informatics Research (CALIBIR) program will address the
clear need to enhance diversity within the biomedical informatics and data science field, particularly the dearth
of underrepresented individuals pursuing graduate programs and careers in different areas of this field. The
CALIBIR program builds on the research strengths in biomedical informatics and data science and the existing
didactic training in biomedical informatics, engineering, statistics, and computer science topics at Wake Forest
School of Medicine and Wake Forest University. The Program Faculty (including the Program Directors) have
vast academic and professional experiences; a history of administration and collaboration on diversity-focused
research and training programs; and ongoing research and funding in the five research domains proposed for
CALIBIR training: Clinical Research Informatics, Artificial Intelligence, Healthcare Informatics, Imaging
Informatics, and Translational Bioinformatics. Thus, we are well-positioned to offer a 10-week summer
research immersion experience to train and educate undergraduate and master’s level underrepresented
students and promote greater interest, exposure, and research experiences in biomedical informatics and data
science. The CALIBIR program will support mentored research training activities of 60 scholars (12 students
per summer). The program's overall goals are to: 1) increase underrepresented students' skills, preparation,
and commitment to participate in cutting-edge biomedical informatics research; 2) offer lectures and hands-on
demonstrations on state-of-the-art biomedical informatics techniques via a “Biomedical Informatics Boot
Camp”; 3) provide group seminars and networking events covering responsible conduct of research, scientific
dissemination, and professional development topics; 4) build trainee experience in scientific communication via
a journal club, writing workshop, and an abstract and oral presentation of their research; 5) cultivate influential
and long-lasting collaborative relationships between trainees and mentors to highlight the value of teamwork in
research and provide an accepting and inclusive environment that will positively impact students from diverse
backgrounds; and 6) encourage underrepresented students to pursue doctoral studies and careers in
biomedical informatics and data science fields through an experience that exemplifies the excitement and
challenges of clinically relevant investigations. The overarching goal of the CALIBIR program is to expand the
pool of underrepresented students who successfully complete a graduate degree in a biomedical informatics-
related field up to a PhD and increase the diversity of the biomedical informatics and data science workforce.
In sum, the CALIBIR program takes advantage of unique strengths, existing infrastructure, and long-standing
collaborations among diverse program faculty to ensure the successful creation and implementation of the
program. It offers several innovative approaches to provide both technical and professional preparation to
recruit and retain underrepresented students in the biomedical informatics and data science fields.

Public health relevance
PROJECT NARRATIVE The CALIBIR program takes advantage of the broad, interdisciplinary research in biomedical informatics and data science within the Center for Biomedical Informatics and the participating faculty laboratories at Wake Forest School of Medicine and Wake Forest University. CALIBIR will provide diverse cohorts of undergraduate and master’s level students, who are underrepresented in the biomedical and behavioral sciences, with an opportunity to participate in biomedical informatics and data science education and research training. The overarching goal of the CALIBIR program is to create a pipeline for well-trained underrepresented students to pursue graduate research and careers in the field of biomedical informatics and data science.